Intervention to Reduce Internalized Stigma (IRIS) among People Living with HIV who use Substances

ABSTRACT
Different facets of stigma (anticipated, enacted, internalized) associated with substance use disorder (SUD)
and with HIV positive status impede cessation of substance use and HIV health outcomes including
antiretroviral therapy adherence and viral load suppression.1-6 Although public stigma is pervasive surrounding
both, individuals can learn to reduce its internalization and mitigate stigma’s negative impacts on their health.
However, interventions promoting this are non-existent in the published literature.
To this end, we propose to adapt an evidence-based stigma-impact reduction intervention, Ending Self-
Stigma (ESS) to reduce stigma and its negative impacts on health. ESS has shown efficacy in reducing
internalized and anticipated stigma in populations experiencing mental health conditions.7 The 9-session
group-based intervention, which uses cognitive behavioral therapy strategies and social cognitive theory
constructs, employs didactic learning and interactive activities to facilitate reductions in internalized and
anticipated stigma.
The purpose of the proposed study is to adapt the ESS intervention for people living with HIV (PLWH) who
also have opioid use disorder (OUD) and/or cocaine use disorder (CUD). In the first year, we will use an
iterative process that starts with formative interviews with service delivery key informants and people living with
PLWH with OUD and/or CUD, and ends with two successive pilot studies with the study population. Through
this process, intervention content will be adapted for this population and intervention delivery will be adapted
for a virtual format via a web-based platform. Then, in years 2-3, a small randomized clinical trial of the
resulting Ending Self-Stigma intervention adapted for PLWH with Substance Use disorder (ESS-HSU) will be
conducted with 70 participants to determine its feasibility and acceptability in addition to collecting data on
proximal outcomes including internalized and anticipated stigma, depressive symptoms, anxiety and perceived
stress associated with stigma. We will also measure distal outcomes including ART adherence, viral load and
substance use (SU) at 6-month follow-up.
The ESS-HSU intervention has the potential for high public health impact by reducing the negative effects
of internalized and anticipated stigma resulting from the pervasive public stigmatization of HIV seropositive
status and SUD on HIV health outcomes and cessation of SU. ESS-HSU would be the first virtual intervention
of this type to be evaluated in a randomized clinical trial. If results are promising, we will seek R01 funding for a
full-scale test of this innovative intervention to determine its effects on a range of health outcomes and
characterize mechanisms of intervention effects.

Public health relevance
PROJECT NARRATIVE The purpose of the proposed study is to adapt the Ending Self-Stigma intervention for people living with HIV (PLWH) with opioid use disorder (OUD) and/or cocaine use disorder (CUD). The intervention will be modified through an iterative process of qualitative interviews with service delivery key informants and PLWH with OUD and/or CUD. There will also be two pilot tests before being tested in a small (N = 70) randomized clinical trial (RCT). Using data from the RCT, bivariate analyses will be conducted and path models will be fit to examine the effect of the intervention on proximal outcomes (internalized substance use and HIV stigmas, depressive symptoms, anxiety and stigma stress) and distal outcomes (antiretroviral therapy adherence, viral load suppression, self-reported substance use and urine toxicology screen for substances). The proposed research has the potential to reduce internalized stigma among PLWH with OUD and/or CUD and impact HIV outcomes and substance use cessation.